Sex differences in circadian output signaling

PROJECT SUMMARY/ABSTRACT
Circadian rhythms are the backing track to the symphony of life. Circadian rhythms not only allow organisms to
coordinate their behavior and physiology with daily and seasonal changes but also temporally coordinate
internal processes across organ systems. However, genetic, molecular, circuit, metabolic, and behavioral
studies of chronobiology have been conducted primarily in male animals. Although the overall architecture of
circadian systems is conserved across phylogeny and between sexes, circadian systems are not identical
between sexes. This proposal exploits the Drosophila melanogaster genetic model to identify sex
differences in circadian output signaling from the brain clock to peripheral metabolic tissues. We have
identified two major knowledge gaps: (1) Sex differences in circuitry and signaling from the brain clock to clock
output regions that communicate time of day to peripheral tissues; and (2) Sex differences in peripheral
responses to circadian entrainment at baseline and when exposed to clock desynchronizing stressors. Our
published and preliminary data has identified sex differences in the role of specific clock output neuropeptides
in regulating circadian behavior and shown that age and high-fat diet have separable effects on dampening
circadian rhythms of locomotor behavior and peripheral gene expression. In Project 1, we will use in vivo and
in silico circuit mapping techniques to identify how sex-specific circuitry interacts with circadian clock outputs,
identify sex specific transcriptional programs that alter morphology, cell number, connections, and physiology
of clock output neurons, and use CRISPR knockout screening to identify specific signaling molecules and
cognate receptors that contribute to sexually dimorphic circadian output signaling. In Project 2, we will use a
novel long-term circadian luminescence imaging approach to identify how circadian gene transcription rhythms
break down in peripheral tissues in response to aging, high fat diet, and the confluence of these stressors in
male vs. female flies. We will also focus on insulin signaling as a candidate clock output molecule entraining
peripheral metabolic tissues and characterize sex differences in insulin release, peripheral responses to
insulin, and insulin-dependent entrainment of peripheral gene expression at baseline, across the lifespan, and
under conditions of nutritional stress including high-fat and high-sugar diets. By investigating neuronal
physiology, specific signaling molecules, circuitry, and behavioral genetics, we will develop a complete picture
of how sex- and mating-dependent differences in circadian behavior and peripheral physiology arise. These
findings will provide important insights into behavioral circuit degeneracy – how sexually dimorphic circuitry
provides very similar circadian output under standard conditions. In addition, we will reveal sexually
dimorphism in how circadian physiology responds to aging and dietary stress. Understanding the fundamental
biology of sex differences in circadian biology across lifespan and stressors will identify principles that allow us
to leverage chronobiology to improve human health in more personalized ways.

Public health relevance
PROJECT NARRATIVE Circadian rhythms allow organisms to coordinate their behavior and physiology with daily and seasonal changes but also temporally coordinate internal processes across organ systems. Although the overall architecture of circadian systems is conserved across phylogeny and between sexes, circadian systems are not identical between sexes. The goal of this proposal is to investigate fundamental biology of sex differences in circadian function from the brain to peripheral tissues across the lifespan and under conditions of dietary stress, identifying principles that will allow us to leverage chronobiology to improve human health in more personalized ways.